Molecular mechanisms of persistence in mycobacteria

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB), caused by the Mycobacterium tuberculosis (Mtb) complex, is the leading cause of death due
to infectious disease worldwide. Treatment for drug-susceptible TB requires a multi-drug regimen prescribed for
a period of six months, longer than for almost any other drug-susceptible infection. The treatment of increasingly-
prevalent drug-resistant TB often demands riskier drugs taken for even longer periods of time. The length of
treatment poses major challenges in terms of cost, side effects, and patient adherence. A phenomenon known
as phenotypic tolerance to antibiotics, in which phenotypic differences among individual cells in a population
allow some of them–known as persister cells–to survive exposure to an antibiotic against which their genomes
do not encode resistance, is a main contributing factor to the protracted therapy for TB. In addition to lengthening
treatment duration, persister cells also represent a source of treatment failure, contribute to TB reactivation after
apparently effective treatment, and constitute a pool of surviving cells from which antibiotic-resistant strains can
eventually emerge. Thus, elimination of persisters could reduce treatment times as well as cut rates of treatment
failure and disease reactivation and slow emergence of drug resistance. However, in order to effectively target
persisters therapeutically, a deeper understanding of how cells enter, maintain, and exit from a persistent state
is required. The goal of this proposal is to dissect the molecular mechanisms underlying persistence in Mtb via
two complementary approaches. In the first, the project will seek to isolate so-called high persister (hip) mutants,
populations of which generate a higher proportion of persister cells than wild type strains, and characterize the
molecular mechanisms by which the hip mutations they carry increase the proportion of persisters. These
mutants will be isolated using a novel filter-based method that takes into account three parameters–type of
antibiotic stress, antibiotic concentration, and time of exposure–to allow for the uncovering of diverse persistence
mechanisms. In the second approach, the project will aim to elucidate the role of inorganic polyphosphate
(poly(P)) in mycobacterial persistence. Specifically, the project will test the hypothesis that poly(P) acts as a
molecular switch to control entry into and exit from a persistent state using a set of genetic knockouts in key
poly(P) regulatory genes. Ultimately, this project will contribute to a molecular understanding of persistence in
Mtb, which will advance efforts to target persister cells therapeutically.

Public health relevance
PROJECT NARRATIVE Persistence–characterized by the transient ability of a portion of cells within an antibiotic-susceptible population to survive exposure to cidal concentrations of antibiotic–is hypothesized to be a main contributing factor to the protracted length of therapy for tuberculosis, and persister cells also represent a source of treatment failure, contribute to TB reactivation after apparently effective treatment, and constitute a pool of surviving cells from which antibiotic resistant strains can eventually emerge. The goal of this proposal is to dissect the molecular mechanisms underlying persistence in Mycobacterium tuberculosis, the most common agent of tuberculosis (TB). Ultimately, this project will contribute to our understanding of persistence in Mtb, which will advance efforts to target persister cells therapeutically to improve patient outcomes, reduce TB transmission, cut costs for patients and healthcare systems, conserve the utility of anti-TB drugs, and ultimately save lives.